2009 Excitatory Synapses and Brain Function Gordon Research Conference

DESCRIPTION (provided by applicant): This proposal requests R13 support for a longstanding, well-attended, and well-received Gordon Research Conference (GRC) on Excitatory Synapses and Brain Function. Perhaps no other structure is more fundamental to our understanding of the brain than the synapse. In the central nervous system, excitatory synapses represent the primary source of information transfer between regions as well as for local interactions within circuits. Synapses also serve as the site of action for many commonly prescribed medications and their disruption contributes to many neurological and psychiatric disorders. These include schizophrenia, autism, depression, substance abuse and addiction, Parkinson's Disease, Alzheimer's disease, traumatic brain injury, stroke and epilepsy. In some cases, synaptic dysfunction is causal in disease, whereas in other cases it represents the downstream sequelae of one or more underlying molecular defects. In either case, a fundamental understanding of the formation, structure, molecular organization, signaling function, and plasticity of synapses is essential to progress in lessening the burden of human neurological disease and for predicting and improving mental health. This conference is unique in its focus on the excitatory synapse, and in its multidisciplinary group of participants including structural biologists, molecular and developmental biologists, cell biologists, biochemists, cell/molecular imagers, biophysicists and physiologists. The conference is intended to relate fundamental insights in excitatory synaptic function to the impairments in synaptic function that occur in disease, as well as the maladaptive plasticity that occurs in substance abuse. The goal of the conference is not to survey abnormalities in each disease, but rather to probe new fundamental insights into synaptic function and dysfunction from a thematic approach. The program has been designed to highlight cutting edge approaches and to stimulate new concepts, methods and technologies within a sound biological framework of fundamental neuroscience. The conference will bring together expert scientists worldwide in an environment that is conducive to discussion and exchange of ideas. The exchange of ideas at this conference has been a driving force for the field. We expect the 2009 GRC on Excitatory Synapses and Brain Function will shape future scientific directions, and provide critical support for the mission of multiple institutes at NIH including NIMH, NINDS, NIDA and NIA. The synapse is the fundamental unit of information processing in our brain. Synaptic dysfunction is responsible for many neurological and psychiatric diseases. This conference brings together experts on excitatory synapses to update progress and stimulate new approaches to improve mental health and reduce the burden of neurological disease.

Public health relevance
Project Narrative The synapse is the fundamental unit of information processing in our brain. Synaptic dysfunction is responsible for many neurological and psychiatric diseases. This conference brings together experts on excitatory synapses to update progress and stimulate new approaches to improve mental health and reduce the burden of neurological disease.